Equity in Maternal and Birthing Outcomes and Reproductive HeAlth through Community Engagement

Project Summary/Abstract
Longstanding racial and socioeconomic inequities in the US, underpinned by historical legacies
of systemic racism, oppression and exploitation, have burdened Black people and increased
their risk of adverse maternal and reproductive health outcomes. Through Reproductive Justice,
anti-racist scholarship and social justice praxis, researchers and clinicians are increasingly
advocating for and innovating approaches that center and empower the community's lived
experience. The Equity in Maternal and Birthing outcomes and Reproductive HeAlth through
Community Engagement (EMBRACE) Center is a multidisciplinary community-academic
partnership to advance maternal and reproductive health for Black people in Allegheny County,
Pennsylvania and augment training in anti-oppression praxis for care providers, researchers,
and policy advocates. Leveraging existing and developing relationships, as well as our
leadership expertise, the EMBRACE Center consists of three multi-level research projects: 1)
implementation of a community health worker model to support postpartum recovering among
Black birthing people at risk for severe maternal morbidity; 2) integration of enhanced
postpartum (4th trimester) and interconception care centering Black families; and 3) evaluation
of policies governing maternal and reproductive health equity among Black populations. Two
components (Community and Training) will provide support and structure across the center to
ensure community partnership and thought leadership in all phases of the work and training and
capacity building for reproductive justice and equity. In line with the Center's vision, researchers
and community collaborators (many of them Black-led organizations) will employ power-sharing
approaches that value diverse forms of knowledge and dissemination processes in equitable,
accessible ways. We expect the work of EMBRACE to result in sustainable approaches and
interventions that will advance maternal and reproductive health equity justice and improve
health and well-being for Black women, femmes, and gender expansive people.

Public health relevance
Project Narrative The Equity in Maternal and Birthing outcomes and Reproductive HeAlth through Community Engagement (EMBRACE) Center of Excellence seeks to advance reproductive health and justice for Black populations in Allegheny County, Pennsylvania via multidisciplinary, community-centered research and training. Academic partners, practitioners and community leaders will work together to implement three multi-level research projects, supported and structured by components that prioritize community ownership, data transparency, and anti- oppression praxis. The intervention and implementation research generated from EMBRACE will address key factors related to maternal morbidity and mortality across the reproductive span among Black populations. Finally, EMBRACE will also set in motion necessary and sustainable improvements in academic-community partnerships, social services and health and health policy in our region.